NIDA PRODUCT PROTOTYPES TO COMBAT DRUG CRAVING CHALLENGE HHS-CAOD-2022-NIDA-0001

NIDA is launching the “Product Prototypes to Combat Drug Craving” Challenge to solicit submissions of product prototypes for decreasing drug cravings and preventing a recurrence of drug use. These product prototypes should be:

Easily accessible and minimally invasive.
Available just-in-time and on-demand.
Suitable for use without detoxification (clearing drugs from a patient’s system) as a precursor.
Substance-agnostic (i.e., could help a patient with any type of substance use). (NOTE: except alcohol, please see “Statutory Authority” section below.)
Suitable for use by many different patients (e.g., different ages, genders, geographic locations, income levels) at different stages of recovery.
Multifaceted and modifiable with different options, where the patient/user can tailor their interaction level or use of the particular intervention or combination of interventions based on their individual needs.